T-tubule membrane remodeling in Drosophila myofiber function and models of myopathy

Project Summary
Muscles are highly specialized cells that provide contraction essential for animal life. A disruption of the elaborate
muscle cell organization underlies human myopathy diseases. In particular, differentiation of the muscle cell
membrane into an extensive tubular membrane network called Transverse (T)-tubules is needed to enable
signaling that coordinates power of muscle contraction. T-tubule disorganization or loss is observed in certain
human skeletal myopathies and cardiovascular diseases, and interestingly, associated mutant genes encode for
membrane regulators with known roles outside of muscle in endocytosis or endosomal trafficking. In flies, we
discovered a regulated T-tubule remodeling program in development, along with the identity of conserved genes
involved at distinct steps: disassembly, remodeling, or reassembly. Importantly, two fly genes function as key
switches for T-tubule disassembly also have human homologs associated with centronuclear myopathy (CNM).
This signifies that regulated T-tubule remodeling and the use of fly models are both likely important contexts to
study, understand and treat human CNM disease. The fly system affords the unique and key advantages of in
vivo imaging of T-tubule membrane dynamics in live, intact muscle cells within a stereotypical developmental
timeframe in combination with a wealth of genetic tools. We established a new framework for understanding T-
tubule dynamics needed both in development and adult muscle remodeling. We identified that class II PI3-kinase
(PI3KC2) and dynamin large GTPase act together as a molecular switch that controls T-tubule membrane
scission and disassembly with muscle cell remodeling. In these studies, we identified that there is concurrent
muscle membrane remodeling not just of T-tubule membranes, but also of the adjacent encircling striations of
costamere integrin adhesion complexes (IACs) that link the underlying contractile sarcomeres to the cell
membrane. We hypothesize a shared PI3KC2-Dynamin switch activity coordinates muscle cell membrane
disassembly of both T-tubules and IACs, and that this switch must be tightly regulated to ensure appropriate
muscle dynamics and prevent myopathy disease. Using our innovative genetic, cellular and molecular
approaches in intact fly muscles at different stages, we will build on our novel findings to determine the functional
relationship between IAC dynamics and T-tubule disassembly. We will, (1) establish a timeline of normal IAC
disassembly and protein components that depend on PI3KC2-dynamin switch activity in normal and induced
muscle remodeling, (2) determine the signaling and molecular mechanisms that promote and mediate a switch
in PI3KC2 and dynamin physical interactions, localization and enzymatic activities for disassembly, and (3)
define how PI3KC2 functions with Rab21 GTPase, another molecular switch, collaborate to integrate T-tubule
and IAC disassembly with integrin endocytosis and endosomal pathways. Importantly, we will establish
conservation and consequences of pathway activity for T-tubule membrane reorganization in ongoing adult
muscle function, with relevance to understanding human muscle disease.

Public health relevance
Project Narrative Muscles are highly specialized and organized cells that provide contraction essential for animal life, and disruption of functional muscle cell organization underlies many human myopathy diseases. In particular, the muscle cell membrane forms an extensive tubular membrane network, or T-tubules, that control muscle contraction; however, little is known about how T-tubules form, functionally organize or remodel with demands from ongoing use, damage or age. Our use of fly models with powerful genetic, cellular and molecular approaches will determine the physiological mechanisms of conserved regulators of T-tubule membrane remodeling critical for muscle function and understanding human disease.